ANALYTICAL CHEMISTRY AND STABILITY TESTING OF TREATMENT DRUGS FOR SUBSTANCE USE DISORDERS. N01DA-19-8950. PERIOD OF PERFORMANCE: AUGUST 4, 2019 - AUGUST 3, 2024.

ANALYTICAL CHEMISTRY & STABILITY TESTING OF TRMT DRUGS